Environmental Exposures, Host, Factors and Human Disease

SUMMARY
Over the past decade, the rapid growth of the logistics industry has brought about a vast rise in mega-warehouse
developments in Southern California, specifically in the Inland Empire (I.E.). This region once known as the
‘Orange Empire’ for its vast agricultural and citrus lands is now third in the United States (U.S.) for mega-
warehouse occupancies, spanning approximately 174 million square feet of industrial space. Warehouse
developments come with significant disruption to the local land use, including increased traffic congestion, noise,
depreciation of property value, and magnifying local air pollution. The logistical activities associated with
warehouses have become a major cause of industrial emissions and progressing environmental pollution. There
is limited research on the environmental and health impact of warehouses. Additionally, to our knowledge, there
has not been a study examining the impact that warehouses and associated logistical activities have on the
health outcomes of neighboring communities. The Inland Empire Warehouse Development and Children’s
Respiratory Health study seeks to leverage a community-engaged approach to evaluate the impact of
warehouses and warehouse-related logistical activities on children’s respiratory health. The diversity supplement
aims to: 1) advance community capacity to conduct research and increase engagement and understanding of
exposure risks, environmental health, and risk factors impacting the respiratory health of children through popular
education workshops, and 2) evaluate the association between the density and proximity to warehouses and the
respiratory health symptoms of elementary school-aged children. This planned data analysis will contribute to
the understanding of warehouses and warehouse-related logistical activities and respiratory health among
children, community concern, and one of the overall goals of the Southern California Environmental Health
Sciences Center (SCEHSC) parent grant. The Candidate will enhance community-engaged research skills and
gain training in environmental epidemiological methods. She will strive to promote Environmental Health Literacy
among all participants and stakeholders through the translation of findings from this diversity supplement and
the parent grant. The objectives align with the SCEHSC aims, advancing scientific research, promoting
community engagement, advancing translational research, and training new researchers. The completion of this
diversity supplement will provide critical insight into warehouse developments and their impact on air pollution,
coupled with expanding our understanding of how the proximity to and density of warehouse facilities impacts
respiratory health in children. This study will be among the first to examine the relationship between warehouses
to childhood and longitudinal respiratory health symptom outcomes. The training will position the Candidate to
pursue an independent academic career and make significant contributions to the field of exposure disparities
and health outcomes among environmental justice communities.

Public health relevance
NARRATIVE The proposed diversity supplement leverages a unique opportunity to both address a community concern and enhances the Candidate’s training in geospatial and environmental community-driven epidemiology by examining the impact relationships between warehousing, air pollution, and respiratory health. This supplement will contribute to ongoing efforts to expand a community-academic partnership to determine the health effects of childhood environmental indirect exposures and inform public health action in the Inland Empire of Southern California. The training will position the Candidate to launch an independent career focusing on the relationship between the built environment and health outcomes with a focus on environmental justice communities.